2023 Chromosome Dynamics Gordon Research Conference and Seminar

Abstract
The 2023 Gordon Research Conference on Chromosome Dynamics organized by Camilla Bjorkegren and
Stephen D Bell will present cutting edge research on chromosome biology. Chromosomes carry the
blueprint of life and aberrations in their structure and function is central to the development of cancer. This
international meeting will be held in Il Ciocco Italy from June 25-30, 2023. The twin objectives of this
conference are to foster exchange of the information and ideas, and to encourage new interdisciplinary
collaborations. Approximately 175 researchers from the various chromosome sub-disciplines will be
brought together. The meeting will feature 3 keynote speakers including two well-established leaders in
the field: Dr. Susan Gasser (ISREC, Switzerland) and Dr. Geeta Narlikar (UC San Francisco, USA) as well
as an emerging leader, Dr. Romain Koszul (Inst. Pasteur, France). Podium presentations will feature
invited internationally-renowned experts, as well as younger scientists whose work will be selected from
the submitted abstracts. Eight additional platform sections covering all major aspects of chromosomes will
be held, including chromosome structure and organization, cohesion and condensation, centromeres and
telomeres, chromosome segregation, meiosis, and chromosome replication and repair. This meeting is
relevant to the NCI mission because of its emphasis on basic chromosome biology, many aberrations of
which are central to the development of cancer. Junior scientists will also have the possibility to attend a
two-day Gordon Research Seminar (GRS) preceding the GRC, organized by Coral Zhou. The GRS will
feature a keynote lecture by Dr. Wendy Bickmore (University of Edinburgh), two sessions with 16 talks by
trainees selected from abstracts, and two poster sessions. There will also be an additional mentorship
session where invited mentors representing a broad range of scientific careers will provide counsel for
trainees through self-selected small group discussions. We anticipate that the intense scientific and
mentoring interactions during both the GRS and GRC will impact cancer research in many significant ways
and help establish productive multidisciplinary research collaborations and further the careers of trainees.

Public health relevance
Project Narrative Chromosome aberrations including DNA mutation and altered chromosome number are a hallmark of cancer, but our understanding of the basic biology of chromosomes is incomplete. In order to be accurately transmitted to daughter cells, the DNA on chromosomes must be replicated and partitioned, and all damage to chromosomes repaired to prevent mutations. This meeting brings together researchers from all areas of chromosome biology to discuss their research, exchange ideas, and establish collaborations that will enable the prevention and treatment of cancer.